Administrative Core

ADMINISTRATIVE CORE
SUMMARY
The Administrative Core benefits from the expertise of the entire administrative staff of
the Center for Visual Science. The PI and administrators, along with Core Directors and
Associate Directors ensure efficient, cost-effective, fair, and scientifically optimal use of
the Technical Services of each of the three Cores. They are additionally supported by
the ad hoc members of the Executive Committee to design and implement supporting
activities to the core, including communication, needs identification, resource planning,
documentation, scholarly output analytics, and human and material resource